Residential Environmental Health Literacy Educational Tools for Vulnerable Populations

Abstract
The Triton Systems Team will develop a prototype Mixed Reality (XR) solution to increase
environmental literacy in urban communities. There are significant environmental hazards within
urban communities that effect the health of families and their environment. These hazards
contribute to cognitive, physical, and environmental health. By providing tools for urban
communities to identify exposures, assess risks and appropriate responses, the HELPR (Home
Environmental Literacy Portal for Residents) app will educate community members on mitigating
hazards to improve their health and the health of their surroundings. XR allows users to access
the portal through their existing devices and visualize what hazards look like in their own home,
identify existing hazards, and react to reduce their risk. The team will develop, test, and validate
the practical implementation of the interface and architecture outlined.
Developing this mobile application within a human factors ecological interface design
framework, the team creates an intuitive tool for the communication of environmental
information and tutorials in users’ native languages. HELPR can be used by homeowners and
renters to frame and respond to environmental health hazards.

Public health relevance
Project Narrative Triton’s Home Environmental Literacy Portal for Residents (HELPR) targets health hazards found in the urban home to enhance health, lengthen life, and reduce illness and disability. For many the process for identifying, removing, and preventing health hazards in the home can be convoluted and difficult to navigate. The innovative technology of HELPR provides location specific identification assistance and proactive action suggestions to improve urban respiratory and general health by mitigating risks in the home.